Systems-level electrophysiology for addiction and reward research

DESCRIPTION (provided by applicant): Addiction is closely linked with dysfunction of dopamine transmission in the brain circuitry of reward. Despite many decades of work, little is known about how systems-level phenomena in this pathway encode information, and how this information regulates behavior. The broad objective of this project is to introduce a new systems-level recording methodology to the arsenal of addiction and reward brain circuitry research. This study will demonstrate the feasibility of combining systems-level with molecular-level neuroscience, using implantable multi-electrodes to record extracellular single-unit activity and selective activation of neuronal subpopulations that mediate reward. Due to the highly interconnected and geometrically distributed nature of dopamine reward circuitry, it has been challenging to discern the network-wide dynamics of pathways recruited in reward-related behaviors such as addiction. To address this problem, the proposed recording instrument will deploy silicon shafts containing high-density electrodes at multiple locations in the brain. Other multi- electrode probe technologies lack the number of channels and geometry to record large numbers of neurons from deep and distributed areas required for this project. The devices proposed here will be built using nanofabrication methods to facilitate minimally invasive insertion of several multi-electrode-containing shafts throughout the mouse brain. Unlike traditional functional scanning techniques such as fMRI, the implantable devices will offer single-unit and sub-millisecond resolution. Functional control of activity in the pathway will be achieved by optogenetically activating dopaminergic neurons in the midbrain, mimicking the action of a rewarding stimulus. To test the ability to resolve systems-level activity of this dopaminergic neuron perturbation, we will implement two recording strategies. In the first approach, we will progressively scan a two-dimensional (2D) probe across an anatomical volume of interest, effectively constructing a high-resolution 3D map of action potential activity. In the second approach, we will simultaneously monitor the response of several brain areas associated with addiction, to capture the activity of up to 2,000 neurons in parallel in several distributed, but interconnected hubs in the mouse brain. In the long term the proposed devices and experimental protocols will provide a new window into the role of collective dynamic phenomena in the brain. Moreover, this technique will have broad impact on many aspects of neurophysiological and behavioral research, including reward-mediated learning and Parkinson's disease.

Public health relevance
Systems-level neuronal interactions are critical to understanding disorders such as addiction, but have been challenging to study in the intact brain. This project will support the development of recording instrumentation and accompanying experimental protocols for high-throughput, systems-level measurements of distributed and interconnected deep brain structures implicated in addiction and reward-mediated behaviors.